CXCL12 regulation of placental development and fetal health

Project Summary/Abstract
Impaired placental function leads to dangerous pregnancy complications such as preeclampsia, intrauterine
growth restriction, placental abruption, and stillbirth. Placental dysfunction is the leading cause of maternal,
fetal, and neonatal morbidity and mortality worldwide and predisposes offspring to higher risks of developing
cardiovascular disease, type 2 diabetes, insulin resistance, obesity, hypertension, and stroke during
adulthood. To improve human health, it is imperative to elucidate the mechanisms causing impaired placental
development. The chemokine, CXCL12 (L12) regulates several processes central to the development of the
placenta (placentation) such as stimulating cell proliferation and migration, vascularization, immune cell
recruitment and cytokine production through direct actions on fetal trophoblast and maternal endometrial and
immune cells. These essential functions are elicited via L12 activating its two receptors, CXCR4 (R4) and/or
CXCR7 (R7); however, the contributions of R4 compared to R7 during placentation remain unclear, denoting a
substantial gap in knowledge. Our group and others demonstrated L12-mediated signaling is strongly
implicated in placental dysfunction and specifically preeclampsia etiology. Defining L12-induced actions
through its two receptors may reveal underlying mechanisms causing placental dysfunction. We developed an
innovative animal model to study L12-dependent signaling at the fetal (trophoblast)-maternal (endometrial)
interface by delivering treatments directly into the uterus. Our published and preliminary data demonstrate
disrupting L12-mediated signaling during the small window of embryo implantation diminishes placental
vascularization, induces autophagy, and creates an excessive inflammatory placental environment later in
gestation. Notably, several observed outcomes mirror those of placental dysfunction, suggesting an imbalance
in L12/R4/R7 signaling may be causative. Preliminary data indicate transitory suppression of L12/R4 signaling
induces lasting placental insufficiency with preeclampsia markers VEGF receptor-1 (sFLT-1) and placental
growth factor (PlGF) remaining elevated months later, at midgestation. Whether excessive R7 activation
contributes to these findings when R4 is suppressed remains uncertain. Our data underscore the importance
of L12 during placentation and provide strong evidence that altering L12-mediated signaling induces enduring
placental effects manifesting later in gestation. Nevertheless, we lack a clear understanding of how L12,
excreted by fetal trophoblast cells, signals through R4 and R7 on trophoblast and maternal cells. This SC1 will
test the overall hypothesize that L12 induces distinct biological responses through R4 versus R7, thereby
differentially impacting placental development, function, and fetal growth. Results from Aim 1 will provide new
scientific knowledge on R4 and R7 functions in placental biology during times impractical to obtain in humans
through characterizing a robust in vivo model and placental phenotype at select gestational times. Mechanistic
in vitro studies in Aim 2 will delineate L12-mediated signaling in fetal and maternal cells.

Public health relevance
Impaired placental function is the root cause of preeclampsia, intrauterine growth restriction, and fetal morbidity and mortality, but the underlying causes of placental dysfunction are not well characterized. Improper signaling of the chemokine CXCL12 (L12) leads to placental dysfunction, but the mechanisms leading to and the potential consequences of altered L12-dependent signaling remain unclear. This proposal will advance the comprehension of L12-induced actions in early placental development to improve pregnancy success and elucidate novel therapies to treat pregnancy complications.